PA TH2Caregiving: Data-Driven Digital Engagement to Assess and Address the Needs of Family Caregivers

PROJECT SUMMARY/ABSTRACT
Family caregivers are often required to provide post-discharge assistance to individuals with disabling conditions,
resulting in strain and negative effects on the caregiver’s health and well-being. While assessing and addressing
the needs of family caregivers has been identified as a priority area, there are no comprehensive programs
designed to assess a family member’s readiness to provide post-discharge care and address unmet needs.
PATH2Caregiving is a nurse-led comprehensive evidence-based transitional care program designed to bridge
this gap by evaluating unmet caregiver needs and implementing interventions specifically tailored to address
those needs. The program includes the Preparedness Assessment for the Transition Home (PATH)©, a
validated, 25-item, self-report screening tool that assesses and prioritizes biopsychosocial and ecological risk
factors for caregiving, and a corresponding Catalog of Caregiver Interventions© designed to minimize the
adverse effects of caregiving post-discharge through education, skill building, support, and links to community
resources. Implementing such a program may mitigate the adverse effects of caregiving by developing a
personalized discharge and transition plan and optimized preparation for the transition home following discharge
from an acute care hospital or inpatient rehabilitation facility (IRF). The goal of this Phase I SBIR project is to
translate the PATH2Caregiving Program© into a usable, acceptable and accessible mHealth platform for iOS,
Android, and web-browsers. The project will involve the development and testing of a mobile application (app)
with minimal features (i.e., a minimum viable product [MVP]) focused on user experience (UX) and user interface
(UI).The app will be tested with caregivers and clinicians of patients being discharged from an IRF. In this Phase
I project we will address the following Specific Aims (SA): SA1: Identify design features for the UI and UX,
operationalization survey and algorithms, and develop the necessary backend architecture for the
PATH2Caregiving platform. It will involve developing the storyboards and further refinement based upon
quantitative and qualitative feedback through end-user focus groups on usability. SA 2: Develop and
computationally test the PATH2Caregiving software platform for accuracy, validity, and solution reproducibility.
SA 3: Conduct usability and acceptability testing of the MVP with a small group of end users, including family
caregivers and clinicians, to evaluate UX through quantitative surveys that include ratings of the features, format,
graphics, and ease of use; and qualitative interviews to assess accessibility, usability, usefulness, and likeability
of platform features. The successful development of the PATH2Caregiving MVP will be the basis for Phase II of
the project that will involve feasibility testing in real-world environments with partnerships in clinical sites, further
refinement of the platform as needed, and development of interoperability features for integration into EHR
systems.

Public health relevance
PROJECT NARRATIVE Family members are often not well-prepared to fulfill the caregiver role for care recipients with disabling conditions who are discharged home from an inpatient rehabilitation facility, placing both the caregiver and care recipient at-risk for poor health and quality of life outcomes. A program to identify and address the needs of caregivers that includes an assessment and tailored care plan using a mHealth application is needed to better prepare them for the caregiver role. Improving caregiver preparation and addressing unmet needs will mitigate health and quality of life risks for caregivers and care recipients.